NY Community-Hospital-Academic Maternal Health Equity Partnerships (NY-CHAMP)

OVERALL: PROJECT SUMMARY/ABSTRACT
The broad goal of the New York Community-Hospital-Academic Maternal Health Equity Partnerships (NY-
CHAMP) is to upend the maternal healthcare ecosystem in New York City (NYC) and New York State (NYS) by
establishing a sustainable, highly collaborative infrastructure for community-centered maternal health science.
We have carefully co-designed, with our partners, a research, training, and community engagement agenda that
will 1) identify and address the comorbid biologic and psychologic pathways linking adverse social determinants
of health (SDoH) to disparities in SMM and MM; and 2) co-create and implement scalable multi-level strategies
grounded in anti-racism and empowerment to inform systems and policy change in our city and region. NY-
CHAMP is set against the compelling backdrop of persistently high rates and disparities in SMM/MM across
urban and rural parts of our state alike, despite a multitude of healthcare facilities and resources. More effective
partnerships that break down siloes and leverage the knowledge and strengths of our diverse communities,
hospitals, academic institutions, and government agencies are essential to assuring equitable access to
culturally congruent, patient-centered care, redressing SMM/MM inequities, and maximizing our collective
impact. We convene Columbia University and Weill Cornell Medicine, four lead community organizations (Black
Women's Blueprint, Caribbean Women's Health Association, Northern Manhattan Perinatal Partnership, and
The Bridge), and a broad coalition of multisector actors to address 3 synergistic Overall Aims. In Aim 1, we will
implement a unified, community-driven research program that will: Project 1) Develop and implement novel
artificial intelligence risk prediction models and a resulting clinical decision support system for SMM, accounting
for SDoH, bias and fairness. Project 2) Conduct a Type 1 Hybrid Effectiveness-Implementation Trial of a novel
doula-delivered cognitive behavioral therapy program holistically designed to address CV, MH, and SDoH
outcomes during postpartum; build trauma-informed and empowerment-based service delivery models; and
strengthen hospital-community care linkages. Project 3) Apply mixed methods to evaluate the effects of and
excess costs attributable to structural racism and SMM/MM and the mitigating effects of two policy interventions
for reducing maternal health disparities. In Aim 2, we will establish the Community Engagement and Policy
Action Core (CEPA) to serve as an enduring platform for iterative community input, co-design processes, and
research dissemination, capacity building, and policy action. In Aim 3, we will establish the Career Development
and Training Core (CDTC) to transform the maternal health research culture and pipeline of early-stage
investigators expertly trained in community partnerships, interdisciplinarity, anti-racism, and diversity, equity,
inclusion, and justice. Our vision is perfectly aligned with the priorities, needs, and assets of our communities
and with the NIH's IMPROVE initiative. Ultimately, NY-CHAMP will alter the underlying structural drivers of
SMM/MM in NYC and NYS and shift the scientific paradigm for excellence in maternal health research.

Public health relevance
OVERALL PROJECT NARRATIVE The broad goal of the New York Community-Hospital-Academic Maternal Health Equity Partnerships (NY- CHAMP) is to launch a novel community-centered research, training, and engagement program that will identify and address the comorbid biologic and psychologic pathways linking adverse social determinants of health to disparities in severe maternal morbidity and mortality (SMM/MM); and with our partners, co-design scalable multi-level strategies grounded in anti-racism and empowerment to reduce SMM/MM and affect systems and policy change for maternal health equity in New York City and State. NY-CHAMP brings together Columbia University, Weill Cornell Medicine, four lead community organizations, and a broad coalition of community, hospital, academic, and government partners in a highly collaborative, paradigm-shifting model for excellence in maternal health research.